Altered protein structures and neoepitopes in lupus neutrophils from dysregulated splicing of messenger RNA

Project Summary/Abstract
The goal of our research is to better define the molecular mechanisms cause and perpetuate
systemic lupus erythematosus (SLE). Based on our discovery that transcripts from a large number
of genes are spliced differently in neutrophils from SLE patients compared to neutrophils from
healthy donors or COVID-19 patients, we propose a novel hypothesis of SLE pathogenesis,
namely that dysregulated mRNA splicing in SLE granulocytes can affect their function and
generate (neo)autoantigens not seen by the immune system before.
We propose to expand and substantiate the analysis of altered mRNA splicing and begin to search
for its cause(s). We will define how specific it is to SLE, understand the relation of altered splicing
to sex, age, disease activity, type I interferons, and patient heterogeneity. Our work will also
embark on the quest to elucidate why mRNA slicing is dysregulated in SLE.
Next, we propose to explore the consequences of altered mRNA splicing in SLE. Although we
have high confidence in the alignment of RNAseq reads to support all the splicing events we
detect, and the transcripts are present at good read counts, it needs to be demonstrated that at
least some are translated into altered proteins. We will continue to use targeted LC-MS/MS to find
evidence for those with novel amino acid sequences. The proteolytic processing into antigenic
peptides presented on MHC seen by T cells will then be explored. We know the MHC haplotypes
of all our donors from the RNAseq data, so can match putative neoepitopes with the right MHC.
Our work will clarify whether the production of novel, and perhaps individual, neo-autoantigens
are a feature of SLE. If so, the production of such antigenic peptides would drive an immune
response against the specific cell type that produces them (rather than all cells expressing the
gene), adding a new element of tissue or cell linage-targeting to the autoimmune response. This
model also introduces a new avenue for the development of therapeutics: modulating mRNA
splicing to eliminate the production of neo-autoantigens. This will only be possible once the
mechanism(s) underpinning abnormal splicing have been elucidated.

Public health relevance
Project narrative This project is relevant to public health because it addresses the molecular mechanisms that cause and perpetuate systemic lupus erythematosus (SLE), a debilitating disease that disproportionately affects women in their 20s to 50s. We will test the new hypothesis that dysregulated mRNA splicing perturbs the function of neutrophils and generates (neo)autoantigens not seen by the immune system before.